Investigating the Perturbation of Bone Health by Per/Polyfluoroalkyl Substances

Project Summary
Per- and polyfluoroalkyl substances (PFAS) are pervasive in everyday life. Their extensive use in consumer
products, industrial processes and fire-fighting foam has led to significant contamination of drinking water and
food resulting in universal human exposure. While many studies have investigated the disruption of lipid
metabolism and immune system function by PFAS, less attention has been paid to the adverse effects of
PFAS on bone health. In light of the epidemiological associations between PFAS and lower bone density in
children and adults and the lack of studies investigating the causality and/or mechanisms by which PFAS could
interfere with bone metabolism, the objective of this study is to begin to define the effects of perfluorooctanoic
acid (PFOA) on bone quality. Our research focuses on the interaction of PFAS with nuclear receptors, a likely
mechanism through which PFAS could perturb bone cell function. We have developed a novel, human-relevant
model in which to study the adverse health effects of PFAS: mice expressing human peroxisome proliferator
activated receptor α (PPARα) fed a diet based on the What We Eat In America analysis in NHANES. Our
working hypothesis is that PFAS reduce bone quality through their interaction with nuclear receptors in multiple
bone cell types. To generate the preliminary data needed to support the proof-of-principle for an association
between PFAS exposure and bone health and to hone our working hypothesis, we propose the following
specific aim. We will define the effect of long term PFOA exposure on cortical and trabecular structure,
osteoblast and osteoclast number and function, and the bone transcriptome. We propose to take
advantage of bone and serum samples collected from experiments already conducted in humanized PPARα
mice, PPARα null mice and PPARα wildtype mice: Study 1 – young female and male mice, fed an adolescent
American diet, exposed to PFOA in drinking water for 6 weeks and Study 2 – adult female and male mice, fed
an adult American diet exposed to PFOA in drinking water for 14 weeks. Biological effects on liver and serum
lipid homeostasis are evident in these mice, which have serum PFOA concentrations similar to occupationally
exposed people. Bone structural, histological, biochemical and transcriptomic data will be analyzed.
Comparison between genotypes will begin to define the contribution of PPARα in PFAS-induced adverse
effects on bone quality. The results of this research will provide essential new data on how PFAS negatively
impact bone health and provide the needed foundation to begin to address a critical gap in PFAS research,
establishing the potential for causality in associations between PFAS and loss of bone quality in humans.

Public health relevance
Project Narrative People are exposed to per- and polyfluoroalkyl substances daily from multiple sources. Epidemiological studies show an association between serum PFAS concentrations and lower bone density in both children and adults. Here, we investigate a new in vivo model to study the mechanism through which PFAS impair bone health.